Developmental Funds

Project Summary/Abstract: Developmental Funds
The current request for CCSG funding is targeted to emerging opportunities at Dartmouth in active faculty
recruitments, Members’ collaborative pilot projects, and new research Shared Resource service capabilities.
Since 2014, NCCC has contributed to the start-up funding of 13 newly recruited Dartmouth faculty, all of whom
now are aligned strategically as Members in NCCC Programs. The sole recipient of CCSG funds, Dr. Miller,
had a 92:1 return on investment, and the broader group of ten recipients of non-CCSG seed funding more than
one-year ago still had an impressive 10:1 return on investment. We have a rigorous pilot project selection
process, as exemplified by the total of 161 applications in the current award period leading to 66 project
awards (41%). In the current reporting period, 18 pilot project applications received a total of $704,104 in
CCSG Developmental Funding. For the 12 awards ($529,212) that have completed their one-year seed
funding period, 12 publications have resulted and $4,349,850 in peer-reviewed ($4,549,850 in total)
subsequent direct cost funding has been secured, an 8:1 peer-reviewed direct cost return on investment. For
the larger portfolio of CCSG, ACS, and philanthropic-funded pilot projects, with 52 awards in the review period
($2,443,546) that have completed their one-year seed funding period, 68 publications have resulted and
$17,761,433 in peer-reviewed ($18,531,234 in total) subsequent direct cost funding has been secured, which
is a 7:1 return on investment across the full portfolio of pilot project seed funding. In conjunction with the
extensive 2018 strategic planning effort conducted following arrival of the new Cancer Center Director, NCCC
has assessed the need for new shared resource services. Currently, we have several candidate services under
evaluation, including the emerging registry resource (Biostatistics), CRISPR services (Genomics & Molecular
Biology), GMP Cell-Gene Transfer Facility (Pathology), and PDX models (Mouse Modeling). Our plans are to
pursue the feasibility of establishing these services on a shared basis by aligning them with an existing Shared
Resource management unit. We are using NCCC philanthropic funds to pilot the provision of these services,
and the existence of RaDar, our central shared resource order-entry system developed by NCCC
Administration, permits us in this evaluative period to track the breadth and intensity of use and any linkage to
Members’ currently peer review-funded projects. The information from this fiscal year will be utilized in July
2019 to prioritize ongoing investments to bring on-line additional new services. In summary, NCCC has a
strategic plan in place for the coming 5-year period and a history of effective investment in key seed-funding
mechanisms. The robust level of activity in NCCC-led faculty recruitment at both Dartmouth College and
Dartmouth-Hitchcock Health, and enthusiasm for building Center-wide collaborations related to the four cross-
cutting themes identified since the arrival of Dr. Leach as the new Center Director, have combined to fuel the
need for access to centrally provided shared access to emerging technological research capabilities.